Leveraging New Approaches to Unravel ABO Blood Group Immunity and Incompatibility

Summary: ABO(H) blood group antigens and corresponding anti-ABO(H) alloantibodies were discovered over
a century ago as the first polymorphisms in the human population and continue to be the most common
immunological barrier to transfusion and transplantation. However, despite the fundamental nature of this
discovery, very little is surprisingly known regarding the factors that govern anti-ABO(H) antibody formation or
the fine details of the ABO(H) alloantigen targets responsible for hemolytic transfusion reactions (HTRs). As a
result, current approaches designed to detect ABO(H) antigens and anti-ABO(H) antibodies largely rely on the
same agglutination strategy leveraged by Landsteiner over 122 years ago. While ABO(H) incompatible RBC
transfusion can result in a hemolytic transfusion reaction (HTR), only half of patients who receive ABO(H)
incompatible RBCs experience this outcome. However, the factors that contribute to variable ABO(H)
incompatible HTRs remain largely unknown. This limitation in our understanding is a direct consequence of the
complexity of the post-translational modifications that comprise ABO(H) antigens and a historical limitation in the
tools needed to study both ABO(H) antigens and the antibodies that develop against them. While a variety of
highly novel tools have begun to revolutionize the field of glycosciences – the study of carbohydrate modifications
– these tools have not been as thoroughly applied to perhaps the most common and arguably most clinically
significant carbohydrate structures within the human population – ABO(H) blood group antigens. Fundamental
questions surrounding anti-ABO(H) antibodies and their target antigens often require disparate areas of
expertise, including glycosciences, immunology, hematology and microbiology, which has directly limited the
study of this foundational discovery in transfusion medicine. To overcome this challenge, we have assembled a
highly collaborative and integrated team of physicians and scientists with expertise in these fields. The combined
collaborative history of the Project leaders (>50 papers and >15 years of collaboration) and the use of newly
developed models and tools specifically designed to define factors that govern anti-ABO(H) antibody
development and the specific ABO(H) targets on RBCs responsible for HTRs. In doing so, this program project
grant (PPG) will provide a unique opportunity to define fundamental features of anti-ABO(H) antibody
development and the ABO(H) targets that result in HTRs that have remained incompletely understood for over
a century. This will be accomplished through 3 distinct Projects and the support of complementary Cores. Project
1: Examining the impact of microbial dynamics on B cells responsible for anti-blood group antibody
formation (Leader: Stowell). Project 2: Convergence of innate immunity and microbial communities in
the regulation of anti-blood group antibody development (Leader: Arthur). Project 3. Defining the distinct
antigen targets and antibody specificities that govern ABO(H) RBC incompatibility (Leader: Cummings).
By leveraging these Projects and Cores, this PPG will answer fundamental questions in transfusion medicine.

Public health relevance
Narrative: ABO(H) blood group antigens were the first human polymorphisms described and corresponding anti-ABO(H) antibodies continue to be the most common immunological barrier to transfusion and transplantation. However, despite their discovery over a century ago, the factors that govern the development of anti-ABO(H) antibody and the consequences of ABO(H) incompatibility remain relatively unknown. Using a series translational studies coupled with a new preclinical model of anti-blood group antibody formation, this overarching program project grant (PPG) will define key factors that govern ABO(H) immunity and incompatibility.